2022 Hemostasis Gordon Research Conference and Seminar

Project Summary/Abstract
We request partial support for the Hemostasis Gordon Research Seminar (GRS) and Gordon Research
Conference (GRC), July 31-August 5, 2022, in Waterville Valley, NH. The 2022 Hemostasis GRC is the 35th
meeting in this series which is widely considered as the premier scientific meeting for hemostasis and
thrombosis research. This important topic closely aligns with NIH strategic goals in two critical areas: 1) to
understand mechanisms and reduce morbidity and mortality from hemostatic and thrombotic diseases,
including stroke, myocardial infarction, venous thromboembolism, and trauma-induced coagulopathy and 2) to
increase the biomedical research workforce. Furthermore, recent research has shown that the traditionally
considered hemostatic system has wider importance beyond clotting, playing roles in inflammation, innate
immunity, obesity, diabetes, and cancer. The Hemostasis GRS/GRC brings together researchers interested in
the biology, biochemistry, and genetics of blood clotting proteins and platelets; physicians treating bleeding
and thrombotic diseases, scientists from pharmaceutical companies developing new therapies for hemostatic
disorders, and trainees and junior faculty who are committed to research careers in hemostasis and
thrombosis. Together, these investigators discuss state-of-the-art research and explore new research
opportunities in hemostasis and thrombosis and their applications in medically related fields. Indeed, many key
advances in this field have debuted at previous Hemostasis GRCs. Internationally renowned scientists engage
and motivate trainees and junior investigators through close interactions and interactive exchanges. Free
exchange of ideas and unpublished research, among all attendees, is a key to our GRS/GRC. Also, a priority is
participation by women, underrepresented populations, individuals with physical disabilities, and young
investigators, including graduate and postdoctoral trainees, and junior faculty. The 2022 Hemostasis GRS is
specifically dedicated to the goal of enhancing the biomedical research workforce through trainee development
activities and mentoring The GRS is organized and run by trainees. It is highly successful and enhances the
profile of trainees at the GRC. The 2022 Hemostasis GRC program includes keynote addresses from two
highly successful scientists, Drs. Robert Montgomery and Edward Plow, 39 talks, and posters. The 8 oral and
4 poster sessions focus on topics including Coagulation: Signaling and Structure; Coagulation and Platelets in
Inflammation; Maintaining Hemostatic Balance; Clot and Deep Vein Thrombosis Structure; Lessons of
Molecular Hemostasis from Organisms that Feed on Blood; Coagulation and Platelets in Chronic Diseases;
and Bleeding and Clotting Control. Importantly, we will continue the practice of holding a “Hot Topics” session
of abstract-derived talks during which 8 trainees present their work.

Public health relevance
Project Narrative The Hemostasis Gordon Research Seminar and Conference enjoy an international reputation as the primary fora at which new advances in the field of thrombosis and hemostasis are unveiled and discussed. These meetings bring together young, emerging, and established investigators whose research focuses on how normal and pathogenic coagulation and thrombosis contribute to various human diseases including chronic and degenerative diseases seen in aging populations.